Core 05: Tracking and Evaluation Core

Project Summary: Tracking & Evaluation Core
The Tracking and Evaluation (T&E) Core supports the LA CaTS Center’s (LA CaTS) overarching vision to
improve health outcomes and address health disparities in Louisiana by providing evaluative assessments to
LA CaTS leadership that facilitate data-driven decisions for shaping initiatives and directing resources that
align with the Center’s mission and theme. Through partnerships with 11 member institutions, LA CaTS has
established a statewide infrastructure for developing and supporting clinical and translational (CT) research in
Louisiana. LA CaTS initiatives are developed and implemented through the efforts of LA CaTS team members
working in 10 Cores located across the state. Since inception, LA CaTS programs have given priority to
supporting studies and initiatives that a) focus on disease states prevalent in Louisiana including diabetes,
obesity, cancer and cardiovascular disease and b) have potential for addressing health disparities and
improving health outcomes in the state’s underserved populations. With the onset of COVID-19 in 2020, a
nationwide focus was placed on health disparities and associated co-morbidities, many of which are LA CaTS
priority disease states. This has increased the long-term importance of the LA CaTS Center’s objective for
supporting CT research that address diseases that have disproportionately negative impacts on vulnerable and
underserved populations. LA CaTS leadership must also ensure a) the effective use of LA CaTS Center
resources; b) an integrated approach to strengthen capacity for cross-Core communication and collaboration;
and c) flexibility to quickly revise or develop initiatives based on needs. For this upcoming 5-year cycle the T&E
Core Specific Aim is to Strengthen and oversee the execution of an internal tracking and evaluation plan that
ensures ongoing monitoring, informative interim assessments, flexibility to pivot priorities, and an annual
evaluation at both the Core-level and Center-wide level for new and continuing initiatives. To accomplish this
Aim, the T&E Core will use mixed methods, including relational, developmental, and utilization-focused
approaches to collect data and develop assessments. Evaluation foci include a) assessing Center strengths,
progress toward achieving specific aims and milestones and identifying opportunities for development; b)
growth in CT research focused on underserved populations and health disparities; and c) assessing use,
quality and costs of programs, resources, and services; budget management, resource allocation, program
development or improvement, and challenges. Close attention will be given to tracking a) growth in LA CaTS
efforts to address health disparities and improve health outcomes in Louisiana’s underserved population and b)
Core initiatives that reflect the Center’s commitment to diversity and collaboration across member institutions
and with CTRs and CTSAs. The T&E Core will a) adapt existing tools and processes and/or b)
develop/implement new data collection, tracking or visualization tools or processes based on need. Completing
this Aim will provide assessments that demonstrate the LA CaTS Center’s active pursuit of the long-term
vision.